Role of Protein Kinase C Mutations in Adult T-Cell Leukemia

Abstract - Role of Protein Kinase C Mutations in Adult T-Cell Leukemia
Human T-cell leukemia virus type 1 (HTLV-1) is the cause of a T cell lymphoproliferative disorder, designated
adult T-cell leukemia lymphoma (ATL). This is a highly refractory malignancy, lacking effective treatment
approaches, with a long-term survival rate of less than four percent. The current project exploits our exciting new
discovery of frequent, recurrent mutations in ATL cells in mediators of the T cell receptor (TCR) pathway including
phospholipase C γ1 (PLCγ1), protein kinase Cβ (PRKCβ), caspase recruitment domain family member 11
(CARD11), and interferon regulatory factor 4 (IRF4), and resultant nuclear factor κB activation and high level
expression of N-Myc. This proposal focuses specifically on possible gain-of-function mutations in PRKCβ in ATL,
the most frequent recurrently mutated gene in ATL, with mutation D427N accounting for more than 70% of these
PRKCβ mutations. First, we will determine 1) if PRKCβ mutation D427N promotes proliferation of T cells in mice,
if T cell proliferation in this setting can be inhibited with PRKCβ inhibitor, midostaurin, and we will identify
downstream gene targets of PRKCβ activation in this setting. Second, we will determine if PRKCβ D427N is
critical for proliferation of ATL cells in immunodeficient mice, and if ATL growth in mice can be inhibited by
midostaurin. We expect this study will provide promising new insights into effective therapy for ATL, which could
have relevance to other lymphoproliferative disorders.

Public health relevance
Narrative - Role of Protein Kinase C Mutations in Adult T-Cell Leukemia Human T-cell leukemia virus type 1-associated adult T-cell leukemia/lymphoma (ATL) is a highly aggressive and usually fatal malignancy despite the use of combination chemotherapy and antiviral agents. This application will characterize protein kinase C (PKC) as a key driver in this malignancy, and PKC inhibitor, midostaurin, as a potential therapeutic agent. Effects of midostaurin on T-cell receptor signaling gene targets in mouse and human T cells in vivo will be examined in order to define its therapeutic potential and assess the role of biomarkers in assessing its activity.